Research Conferences: Communication Sciences & Disorders

This application seeks support for a series of five, 1 Va day topicallyoriented research conferences designed to stimulate, educate, and guide research on emerging topics in communicationsciences and disorders (CSD). These conferences, held immediatelybefore the annual Convention of the American Speech-Language- Hearing Association (ASHA), will present research that has important clinical implications for the studyof communication processes and disorders. The goals of these conferencesare to: 1)provide forums that facilitate discussion amongscientists and clinicians regarding research developments;2) foster continuity of interactions among scientists and clinicians in CSDand related fields; and 3) contribute to the development of new investigators, particularly Master's and Ph.D. students and post-doctoral fellows who are members of racial/ethnic minoritygroups. Funds are requested to support 10 minority student travel fellowships. Including the November 2001 conference, ASHA has successfully coordinatedeleven conferences since 1991. The conferencesrepresented full or collaborative funding efforts between NIDCD, ASHA, and on one occasion, the NICHD. Plans for conference organization, conference formats to be used, mechanisms for supporting attendance by student fellowship recipients, conference evaluation, and materials dissemination are listed in the application. Mechanisms and criteria for selecting topics for conferencesin years 1-5, as well as topics and speakers under consideration, are included. Five years of support is requested to allow for advance planning by conference participants and to facilitate the recruitment of speakers. Future research directions, includingpossible clinical research projects, will also be a prominent feature of each conference.